Extracellular Vesiclemediated Regulation of Metabolism

Project Summary/Abstract
Adipose tissue dysfunction is at the forefront of metabolic disturbances in obesity and type II diabetes,
making it a promising target for pharmacological intervention. This active, energy-sensing, endocrine organ
secretes number of factors that have profound effects on systemic metabolism, in addition to its role in
sequestering potentially toxic lipids species. Proper function of adipose tissue is maintained by cross-talk
between resident tissue cells including adipocytes, endothelial cells, immune cells and fibroblasts, a process that
is disrupted in the obese condition. The efficiency at which the adipose tissue responds to nutrient stresses can
mean the difference between sustained whole-body metabolic homeostasis or pathology. My recently published
work describes the finding that cells in adipose tissue exchange extracellular vesicles (EV) that are rich in
signaling proteins, lipids, and, potentially miRNAs. These transfer events are dominated by an endothelial-to-
adipocyte axis; however, adipocytes also secrete EVs that are taken up but other cells in the tissue such as
macrophages or mural cells. Furthermore, we found that under the energetic stress of fasting, endothelial cell
EV secretion is enhanced and targeted to adipocytes. This work has opened up vast potential for the
discovery of novel signaling pathways between these cells that may provide an understanding of what
pathways support healthy vs maladaptive adipose tissue remodeling under the nutrient stress of obesity
or fasting. Preliminary data suggests that endothelial cell EVs support adipocyte ATP production during
mitochondrial energetic stress by increasing adipocyte glycolytic reserve. Furthermore, adipocyte EV production
is enhanced in the context of mitochondrial dysfunction, which we predict will regulate systemic metabolism.
Thus, I hypothesize that under energetic stress, adipose tissue endothelial cells and adipocytes work
synergistically through EV production to modulate whole body metabolism. The first Aim will test the
hypothesis that endothelial cell EVs reprogram adipocyte metabolism to promote efficient adaptation of the
adipocyte to metabolic stress. Aim 2 will evaluate the concept that energetic stress stimulates adipocytes to
secrete EVs that alter systemic metabolism. The general approach will take advantage of both in vitro cell culture
techniques as well as recently generated mouse models of cell-specific mitochondrial dysfunction or cell-specific
suppression of EV production. This proposal will give me the opportunity to be trained in metabolic tracing
techniques, mouse physiology, and human tissue acquisition by highly skilled specialists in the Scherer lab and
throughout UT Southwestern. Successful completion of these aims has the potential to open a new area of
research to decipher EV-mediated signaling pathways in metabolic regulation.

Public health relevance
Project Narrative Obesity and the resulting type II diabetes is a global public health problem. One way we can potentially combat this problem is by understanding more about small vesicles released from cells in fat tissue that critically mediate the information exchange between fat cells and other cell types. The goal of this project is to characterize and manipulate these vesicles to ameliorate the negative health effects of obesity.